RENAL MECHANISMS OF K DEPLETION IN METABOLIC ACIDOSIS

The purpose of the proposed studies is to determine the role of aldosterone in the maintenance of potassium (K) depletion during chronic metabolic acidosis (CMA). Hypokalemia and K depletion are common findings both in clinical and experimental CMA. In K depletion induced by dietary K restriction, we have demonstrated a renal adaptation for K conservation using isolated perfused kidneys from rats. However, the adaptation for K conservation was not functioning when kidneys from rats with K depletion secondary to CMA were perfused at normal pH. This lack of K conservation in vitro could not be attributed to increased sodium excretion although an increase in sodium excretion and urine flow are likely the etiologies of the initial K loss which occurs in early CMA. Aldosterone levels are likely increased during CMA and this hormone is a potent stimulus of K secretion. In the present study, adrenalectomized (ADX) rats will be rendered acidotic while receiving dexamethasone and low or high doses of aldosterone replacement or no aldosterone replacement. The degree of K depletion and acidosis will be assessed in balance studies. Kidneys, from ADX rats replaced with aldosterone during CMA, will be perfused at normal pH. If an elevation in aldosterone mediates K loss during CMA, kidneys from acidosis rats on low aldosterone replacement should react normally to K depletion and conserve K. These studies will provide further understanding in renal handling of K and factors regulating K conservation.